Use of microfluidic tumor cultures to enable clinical trials of therapies for ovarian cancer

ABSTRACT
High-grade serous ovarian carcinoma (HGSOC) is the most common and lethal subtype of ovarian cancer with
a median 5-year survival rate of ~20%. 70-95% of patients with late-stage HGSOC recur or progress with current
chemotherapeutic regimens making HGSOC the leading cause of gynecological cancer-related deaths in the
developed world. Immunotherapy approaches, including immune checkpoint blockade (ICB
), have
also had only
limited success for treating HGSOC. This motivates the need to
develop novel chemotherapies and immuno-
therapies for treating ovarian cancer. This goal is being pursued by the Ovarian Cancer SPORE (P50) at Mayo
Clinic. The SPORE consists of three research projects and four cores. The latter include Biospecimens and
Patient Registry (Core B) and Animal Models (Core D). In Project 2, the SPORE is seeking to assess efficacy
of a novel chemotherapy agent, topoisomerase 1 inhibitor (TOP1i), for treating PARPi and platinum-resistant
disease. In Project 4, the SPORE members are developing NK-cells genetically engineered for enhanced per-
sistence and target specificity. For preclinical testing, both projects rely heavily on the Animal Models Core,
focusing on patient derived xenograft (PDX) mouse models of HGSOC. While incredibly useful, mouse models
have significant challenges that include high cost, limited throughput and lack of human tumor microenvironment
(TME).
The objective of our competitive revision project is to implement novel IMAT-funded microfluidic cancer cultures
for preclinical and clinical testing within the Ovarian Cancer SPORE at Mayo Clinic. The Revzin lab has devel-
oped microfluidic devices for culturing: 1) patient-derived organoids and 2) tumor explants. Like PDX mice, our
microfluidic cancer cultures utilize patient tissue but offer benefits of simplicity, lower cost and much shorter
turnaround time. Microfluidic tumor explant cultures have the additional benefit of preserving patient-specific
TME, complete with immune and stromal cell compartments. In this project, our team will test the hypothesis
that microfluidic cancer cultures serve as an enabling technology for assessing the efficacy of novel ovarian
cancer therapies and as companion diagnostics for clinical trials run by the Ovarian Cancer SPORE.
Impact: This competitive revision project represents a unique opportunity to incorporate recently developed,
IMAT-funded microfluidic cancer cultures into Phase I clinical trials of ovarian cancer therapies. Successful com-
pletion of this project will establish the utility of our cancer culture devices as companion diagnostics, enable
potential Phase II trials, and pave the way for commercialization of this exciting technology.